Mechanism of cold storage lesion resistance in hibernating ground squirrel platelets

Project Summary
Hibernating ground squirrels have dramatically decreased heart rates (3-5 beats per minute) and blood flow,
which should put them at risk of forming blood clots. In response, they have several adaptations during
hibernation that prevent blood clotting, including 3-fold decreases in Factors VIII (FVIII) and IX (FIX), and 10-
fold decreases in von Willebrand factor (vWF), neutrophils, and platelets. The Central Hypothesis ground
squirrel platelets are resistant to in vivo and in vitro cold storage lesions with some changes in the platelet
proteome. This could be due to a combination of altered signaling pathways, resistance to cold-induced cellular
damage, and interactions with extracellular factors. This adaptation could be reflected in differential protein
expression, signaling, and ligand binding of ground squirrel platelets stored in the cold either in vitro or in situ.
In previous research, we found several candidate pathways that differ between human and ground squirrel
platelets and also decreased cold induced activation of apoptosis-associated pathways in ground squirrels.
The three Specific Aims of this proposal are to 1) determine which signaling pathways contribute to cold
storage resistance, 2) determine how ground squirrel platelets resist cold storage lesions, and 3) determine the
effect of extracellular storage conditions on platelets. This project is innovative because we are pioneering
the use proteomic and metabolomic techniques to determine how ground squirrel platelets are resistant to cold
storage lesions in platelets. This research could lead to medical advances to treat thrombocytopenia, store
human platelets in the cold for transfusions, and regulate blood coagulation in cases of accidental or induced
hypothermia.

Public health relevance
PROJECT NARRATIVE: The proposed research is clinically relevant as it could lead to the generation of cold storage lesions in platelets, extending their availability for transfusions. By studying hibernating 13-lined ground squirrels, the project supports objective 1 of the strategic vision of the NHLBI to “understand normal biological function and resilience” in exploring natural resilience to cold storage lesions in platelets. By involving undergraduates in this project both in and out of the classroom the project supports objective 8 to “further develop, diversify, and sustain a scientific workforce capable of accomplishing the NHLBI’s mission”.